Genetic and Dietary Interactions in MMR Deficient Colon Tumorigenesis

Mouse genetic models of Lynch syndrome (LS)/defective MMR (dMMR) driven tumorigenesis produce small
intestinal tumors. However, long-standing collaborative work of the Co-PIs has now developed a new mouse
model that causes LS/dMMR tumorigenesis in the mouse colon by integrating the genetic and environmental
etiology that mimics that of the human. In the Villin-cre, Msh2loxp/loxp, TgfbRIIhu/hu mice (VMshThu), homozygous
inactivation of Msh2 in intestinal and colonic epithelial cells causes tissue tissue-specific dMMR. Further, “G”
residues in an otherwise “A” stretch in the mouse TgfbRll gene were altered by CRISPR/Cas9 to be oligoA,
replicating the oligoA in the human gene that makes TgbRll a key target of dMMR. The mice develop intestinal
tumors with the unique histopathologies of flat adenoma progressing to mucinous invasive carcinoma
characteristic of LS/dMMR tumors, and every tumor has a mutation in the oligo A of the “humanized” TgfbRII
gene. Feeding a purified rodent western-style diet (NWD1) to VMshThu mice shifts tumor penetrance into the
colon, producing the same unique pathologies as in human LS/dMMR. The NWD1 recapitulates intake for the
mouse of several nutrients at levels of each epidemiologically linked in western-societies to higher incidence of
colorectal cancer. This new model has very high relevance to human LS, including historical data linking dietary
shift in human LS to colon penetrance, as well as for somatically linked dMMR and sporadic colon tumorigenesis
in the general population.
Our published and submitted data establish that feeding NWD1 to wild-type mice profoundly alters function of
intestinal stem cells in homeostasis and tumorigenesis, with underlying changes in stem cell programming and
accumulation, spectra and signature of mutations. Therefore, we hypothesize shift to colon tumor penetrance
by feeding NWD1 to VMshThu mice is due to altered colonic stem cell function. Aim 1 dissects alterations in
function, programming, epigenetic and genetic changes induced by NWD1 in VMshThu mice in Lgr5hi, Bmi1+
and Aldh1+ colonic stem cell populations. Emphasis is on the Tgfb, Wnt signaling, DNA repair and oxidative
phosphorylation pathways, and extended globally. Aim 2 addresses the fundamental public health issue of
persistence of specific programming, epigenetic and genetic changes in long-lived colonic stem cells and their
progeny upon switching the protumorigenic NWD1 back to purified control diet. Aim 3 dissects molecular
changes that characterize the progression of the unique benign flat adenomas to mucinous invasive
carcinomas. Further, using unique RNAseq data bases of LS patients compared to average risk individuals for
the uninvolved mucosa, and for adenomas and carcinomas of LS and dMMR patients, correspondence between
genes and pathways in the mouse model and in human will be determined. This will prioritize targets for
development of markers of risk and progression and for further mechanistic dissection.

Public health relevance
A new mouse model closely reflects the combination of genetic and dietary factors that cause development of human colon tumors that have defects in DNA mis-match repair. This model will be used to understand the molecular mechanisms of this genetic-environmental interaction in stem cells, how changes in stem cells persist over long periods and if they can be reversed, and which changes are fundamental in the progression from normal primed mucosa to benign and on to invasive tumors. The potential clinical importance in detection, prevention and treatment of these unique tumors is very high.